Understanding the causes of DNA methylation response to methylmercury: a novel approach to quantify genetic, environmental, and stochastic factors

PROJECT SUMMARY
Environmental toxicant exposures correlate with changes to DNA methylation, or chemical modifications to DNA
that regulate gene expression, but the mechanisms underlying these correlations are unknown. DNA methylation
can differ in genetically identical individuals, allowing different phenotypes to develop from identical genotypes
following exposure. These results suggest specific cellular responses to chemicals that lead to environmental
differences in phenotype. In addition, unexposed genetically identical individuals show variability in DNA
methylation, indicating that some differences are stochastic (i.e., probabilistic). In genetically different individuals,
DNA methylation patterns correlate highly with genotype, both in the absence and presence of chemical
exposure, indicating that some DNA methylation is under genetic control, and that some DNA methylation
responses to chemicals occur in some genotypes more than others (gene-environment interactions). Here, I will
test the central hypothesis that these four sources each explain equal proportions of the total DNA methylation
response in genotypically different mice with developmental exposure to a model chemical, the heavy metal
methylmercury (MeHg). MeHg is an ideal model chemical because it is of strong public health concern, there are
known phenotypic differences in exposed humans and rodents, and MeHg does not cause DNA damage, which
independently affects DNA methylation. My career development goal is to integrate new training in statistical
genetics with my background in environmental epigenetics to do research that is both mechanistic and
translatable to human populations. I will leverage a classic F2 intercross design between two inbred mouse
strains, one susceptible (CAST/EiJ) and one resistant (C57BL/6J) to MeHg neurotoxicity. F1 hybrid mice are
generated with reciprocal crosses between parent strains, and F2 hybrid mice by crossing F1 mice with opposite
parentage. F1 mice are genotypically identical. F2 mice are genotypically different but carry no DNA sequence
not also present in F1 mice. I will measure DNA methylation levels in hippocampus from F1 and F2 mice both with
and without developmental exposure to an environmentally relevant dose (500 ng/g) of MeHg in maternal diet.
DNA methylation differences in F1 exposed vs. control mice will represent environmental effects; hypervariable
DNA methylation in F1 control mice will represent stochastic effects. Genetic sequence variants that predict DNA
methylation in F2 control mice will represent genetic effects; sequence variants that predict differential
methylation in F2 exposed vs. control will represent gene-environment interactions. These results will provide
insight into causes of inter-individual differences in MeHg neurotoxicity. Critically, this work will improve our
mechanistic understanding of DNA methylation response to toxicants.
!
!

Public health relevance
PROJECT NARRATIVE Environmental chemicals that do not damage DNA may still contribute to environmental disease risk by disrupting chemical modifications to DNA that control gene expression, termed “epigenetic marks”; these modifications including DNA methylation. My research will leverage a unique study design to capture genetic, environmental, stochastic, and gene-environment interaction effects on DNA methylation of the neurotoxic heavy metal, methylmercury. This work will shed critical light on mechanisms underlying chemical effects on DNA methylation, which will directly enable public health protection from chemicals with epigenetic mechanisms of action.